HYPOXEMIA ON BLOOD PRESSURE DURING OBSTRUCTIVE SLEEP APNEA

This study will examine the relationship between blood oxygen levels and blood pressure changes in patients with obstructive sleep apnea. Subjects will undergo polysomnography monitoring during a morning nap. Arterial blood samples will be collected at 3 second intervals during and following obstructive apnea. Arterial pressure will be measured non- invasively by finger cuff. Sample runs will be repeated while the subject sleeps breathing supplemental oxygen.